Extracellular Matrix Biomechanical Properties Contribute to Aneurysm Formation in Marfan Syndrome

Project Summary/Abstract
Marfan syndrome (MFS) is the most common inherited connective tissue disorder, caused by mutations in the
fibrillin-1 (FBN1) gene, affecting 1 in 5,000 individuals. Aortic root aneurysms lead to aortic dissection or rupture,
resulting in reduced life expectancy unless preventative aortic surgery is performed. Normally, aortic wall
homeostasis depends on SMC sensing and responding to ECM mechanical force in a process called
mechanotransduction. Dysfunctional ECM maintenance results in aortic wall stiffening, but the role of
mechanotransduction in aneurysm development remains controversial. Furthermore, mechanisms driving focal
aneurysm development restricted to the aortic root (the segment most proximal to the aortic valve) despite
systemic effects of FBN1 mutations are poorly understood. SMCs populating the aorta are derived from specific
embryologic origins such that the aortic root is derived from the second heart field (SHF) and ascending aortic
segments arise from neural crest (NC). We have developed an induced pluripotent stem cell in vitro system to
model embryologic derived vascular pathology. Utilizing an iPSC model relinquishes the dependance for surgical
tissue specimens and opens the door for personalized precision medicine. My preliminary work showed that
iPSC-derived SMC grown on varying stiffness plates demonstrated a distinct embryologic response to increasing
ECM stiffness. The proposed study will advance our current understanding in ECM-SMC mechanotransduction
during aneurysm formation using two complimentary aims. Aim 1 will assess the transcriptomic effects of ECM
stiffness and composition on SMCs from both embryologic origins by applying single cell RNA sequencing to
cells grown on varying stiffness and ECM composition. The composition and mechanical properties of ECM
produced by each embryologic origin SMC will be compared with atomic force microscopy and mass
spectrometry. Aim 2 will investigate embryologic dependent ECM stiffening by utilizing iPSC-derived SMCs
transduced to overexpress mannose receptor 2 (MRC2) to characterized intracellular collagen recycling in vitro.
A transgenic lineage traced murine model will be used to characterize TGF-b effects on MRC2 induced ECM
pathology in vivo. These studies will generate a greater understanding of how altered ECM composition and
stiffness influences ECM-SMC mechanotransduction to provide insight into new therapeutic targets to prevent
aneurysm formation. The proposed research training plan features direct mentorship from a diverse committee
of clinician-scientist and access to state-of-the-art facilities and techniques. The plan incorporates professional
development and career planning strategies, utilizing collaborative resources between Cardiothoracic Surgery,
Cardiovascular Medicine, and the Cardiovascular Institute to maximize my training potential.

Public health relevance
Project Narrative Aortic root aneurysm, or weakening and dilation of the wall of the aorta, leads to dissection or rupture and reduced life expectancy in patients with Marfan syndrome unless early surgical repair is performed. Mechanical forces generated between the extracellular matrix and vascular smooth muscle cells are transduced into biological intracellular signals that contribute to aneurysm development and progression. Understanding the embryologic specific cellular response to a remodeled extracellular matrix will identify new and novel therapeutic targets to slow or prevent aneurysm formation in Marfan syndrome.